Cell-Free Hemoglobin Induces Endothelial Mitochondrial Oxidative Damage Causing Extracellular DNA Release

PROJECT ABSTRACT
Sepsis is a critical problem around the world causing 20% of all global deaths. The lack of highly
effective therapeutics leaves critically ill patients with systemic organ dysfunction often caused
damage the vascular endothelium. Our lab has shown that one of the drivers of vascular
dysfunction in sepsis is circulating oxidized cell-free hemoglobin (CFH). During septic conditions,
red blood cells become increasingly fragile leading to lysis and release of CFH into the vascular
circulation allowing for oxidation from ferrous (2+) and oxidized ferric (3+, methemoglobin)
forms. Data from our lab demonstrates that only the oxidized 3+ form of CFH induces
microvascular barrier dysfunction. However, the intracellular mechanisms underpinning this
dysfunction are not well understood. My preliminary studies suggest that oxidized CFH causes
mitochondrial dysfunction such as increased superoxide production and loss of total
mitochondria. In parallel to circulating CFH being increased in septic patients, there is increased
circulating extracellular mitochondrial DNA (mtDNA) during sepsis. Importantly, the mechanism
underlying release of mtDNA during sepsis remains a key knowledge gap. In addition, it is
unknown whether the mtDNA is released as freely soluble molecules or if it is inside
extracellular vesicles (EVs). Understanding if mtDNA is contained inside EVs could inform
potential effects, distribution, and stability of the circulating mtDNA. In this project, I will test
the hypothesis that CFH-induced oxidative damage causes mtDNA release from the vascular
endothelium leading to downstream loss of macrovascular barrier integrity. The first aim of this
project focuses on identifying the mechanisms behind CFH-induced oxidative damage and its
role in mtDNA release from the pulmonary microvascular endothelium. We will evaluate the
impact of CFH on mitochondrial oxidative damage and permeability pore activation. In addition,
we will quantify whether the mtDNA is freely soluble or contained inside EVs, and if
antioxidants block this secretion. The second aim of the project will determine the effect of
mtDNA on endothelial barrier function. We will also use platelet poor plasma from a highly
characterized prospective cohort of sepsis patients to quantify circulating mtDNA and correlate
levels with mortality, ARDS development, and markers of endothelial damage. At the
conclusion of this study, we will have uncovered a novel molecular mechanism of CFH induced
vascular dysfunction, and characterized both the effects of mtDNA and how it is released from
endothelial cells. This proposed project will provide multidisciplinary experience and growth to
establish the foundation for a successful career as a mechanistic and translational scientist.

Public health relevance
PROJECT NARRATIVE Circulating CFH and mtDNA are both associated with severe sepsis in patients. Here, we present a novel link between oxidized CFH, release of mtDNA from the vascular endothelium and increased endothelial permeability.